Developing an inhibitor of EIF2AK1 to overcome ineffective erythropoiesis in myelodysplastic syndromes with ringed sideroblasts

ABSTRACT
Mutations in the splicing factor SF3B1 (SF3B1MT), which occur in 20% of patients with myelodysplastic
syndromes (MDS), are the hallmarks of MDS-RS, an MDS subtype characterized by the accumulation of
ringed sideroblasts (RS) in the bone marrow. SF3B1MT are found in different hematopoietic cell types but
preferentially deregulate erythroid progenitors. Although MDS-RS has a low propensity for leukemic
transformation, most patients with MDS-RS have severe anemia and depend on regular blood transfusions
despite the increased risk of iron overload and other adverse outcomes.
The only agent approved for the treatment of transfusion-dependent MDS-RS patients who are ineligible
for or have no response to erythropoiesis-stimulating agents is luspatercept, an inhibitor of TGFβ signaling.
However, luspatercept has a response rate of less than 40%, which underscores the need for alternative
treatment options that can alleviate impaired erythroid differentiation in these patients.
In our previous study, we identified the EIF2AK1 response to heme deficiency as a potential driver of the
SF3B1MT-induced arrest of erythroid differentiation. We therefore hypothesize that pharmacologically inhibiting
EIF2AK1 activation overcomes ineffective erythropoiesis in patients with SF3B1-mutant MDS-RS. To test this
hypothesis, we will pursue the specific aim of developing a small-molecule inhibitor of EIF2AK1 activity for
proof-of-concept studies in SF3B1-mutant MDS samples. The findings of this aim will provide a direct line
of sight to future compounds suitable for clinical development.
We have partnered with the Institute of Applied Cancer Science at MD Anderson Cancer Center to develop
small molecules targeting the EIF2AK1 pathway in MDS-RS. Our multidisciplinary team has already identified
several EIF2AK1 inhibitors that have low nanomolar potency, are highly permeable and free of efflux, and have
good selectivity relative to other members of the EIF2AK family of protein kinases. In the proposed work, we
will functionally validate these candidates using cellular assays (employing primary cells, induced pluripotent
stem cells, and genetically engineered cell lines) that we have developed over the last 3 years. If successful,
this study will enable the development of the first inhibitor of EIF2AK1 activity.
The proposed work has implications for the development of therapies to achieve long-lasting hematological
responses in transfusion-dependent MDS-RS patients. Given that EIF2AK1 inhibition is one of the most
promising therapeutic approaches for sickle cell anemia to date, the results of our work may have a broad
spectrum of application.

Public health relevance
PROJECT NARRATIVE Myelodysplastic syndromes with ringed sideroblasts (MDS-RS) are characterized by significant anemia. Patients with MDS-RS are transfusion-dependent and die from a shortage of red blood cells and the side effects of iron overload due to their constant need for these transfusions. Our study, aimed to develop a new compound targeting the EIF2AK1 pathway to heme deficiency, has implications for the development of a new therapy able to achieve long-lasting hematological responses in this cohort of patients.